Novel taxane-site tubulin ligands with a dual apoptosis and senescence-inducing mechanism of action

PROJECT SUMMARY
Senescence, like apoptosis, is an established tumor suppressive mechanism that protects against cancer
development by inducing sustained proliferative arrest. Apoptosis and senescence are common fates of cancer
therapy and both contribute to clinical response. When cancer cells receive a lethal dose of a cancer
therapeutic, they typically execute apoptosis. Conversely, cellular damage that results from sub-lethal doses
induces a senescent fate. Although therapies that trigger stable senescence (pro-senescent) are beneficial
because they suppress proliferation, senescent cancer cells can resume proliferation, often with more
biologically aggressive features, therefore the durability of senescence is an important pharmacologic property.
We have designed and synthesized congeners of the taxane-site tubulin molecule (+)-discodermolide (DDM),
that potently induce cell death AND senescence in taxane-refractory triple negative breast cancer models.
Pleasingly, the senescent phenotype induced by these analogs is significantly more durable than the parent
molecule, Taxol or other cytotoxic drugs, thereby improving the potential for prolonged anti-tumor efficacy.
Using X-ray crystallography, we will continue to evolve the chemistry of DDM to better engage underexplored
residues of the taxane pharmacophore to address whether differential occupation of DDM congeners impacts
pharmacology, cell fate and metabolic stability. We will also generate fluorescent DDM molecules to track the
distribution and longevity of DDM-stabilized microtubules using time-lapse imaging. Multiplexed, dose-
response modeling in taxane-refractory cancer cell lines will primarily guide the selection of lead DDM
molecules for in vivo analyses.
In Aim 2, we will use X-ray crystallography and Cryo-EM to decipher DDM-tubulin and DDM-microtubule
interactions, of lead DDM congeners. These results will feed back to Aim 1 to guide more efficient chemical
optimization and potentially provide mechanistic insight for the durable senescence of DDM molecules.
In Aim 3 we will evaluate the optimal dosing and in vivo safety of lead DDM molecules in C57BL/6 mice,
focusing on hematologic, neuropathic and behavioral metrics, as well as histopathologic analyses. Anti-tumor
efficacy in models of Taxol-resistance using patient-derived breast cancer xenografts will also be evaluated.
This interdisciplinary, collaborative program will employ chemical synthesis, structural biology and phenotypic
screening tactics to develop highly efficacious and metabolically stable DDM analogs that mobilize both
apoptosis and senescence cell fates to maximize tumor suppressive capabilities.

Public health relevance
Therapeutics such as Taxol are indicated for the treatment of patients with breast, ovarian and lung malignancies; however, resistance frequently emerges and/or patients develop toxicities that limit the duration of treatment. We have engineered novel Taxol-like molecules that cause both apoptosis and durable senescence in therapeutically recalcitrant tumors and will use chemical, molecular and biological methods to optimization these molecules for therapeutic efficacy and tolerability. The long-term goal is to generate best-in- class Taxol-like molecules rigorously evaluated to meet pre-clinical efficacy and toxicity benchmarks.